Maternal stress and blood sugar metabolization during pregnancy, and associations with adverse outcomes.

Gestational diabetes mellitus (GDM) impacts an estimated 3% to 9% of pregnancies, increasing the risk of serious
health complications for mother and child. The identified risk factors for developing GDM include both individual
characteristics (e.g., higher body mass index, advanced maternal age) and heritable factors (e.g., family history of
Type 2 diabetes, historically marginalized racial/ethnic identity). However, approximately 50% of GDM diagnoses
occur in the absence of any known risk factor(s). Additional research on biopsychosocial factors related to glucose
metabolism, such as mental health and stress processes, may help to identify individuals at risk. We hypothesize that
there will be associations between maternal mental health, glucose metabolization, and GDM related adverse
pregnancy outcomes that are moderated by stress, and that the magnitude of the of these associations underlay GDM
health disparities experienced by African American (AA) and Native American (NA) women in comparison to non-
Hispanic white (NHW) women. This project will: 1) identify stress-related variables that moderate associations
between maternal mental health and GDM-related health outcomes; 2) delineate associations among maternal
mental health, stress, glucose metabolization, and related adverse outcomes, differ among AA, NA, and NHW
women; and 3) increase our understanding of how psychophysiological stress reactivity interacts with maternal
stress and mental health, to predict glucose metabolization during pregnancy, and associations with adverse
perinatal outcomes. A retrospective study of 4,845 de-identified pregnancy-related medical records of Sanford
Health patients, and a prospective study which follows 150 pregnant women recruited from Sanford Health prenatal
care providers will be conducted. Data from medical records and prospective assessments will be used to identify
associations between maternal health, mental health, blood glucose metabolization and pregnancy outcomes.
Indicators of stress will be tested as moderators in these associations. These analyses will identify which combinations
of maternal depression, anxiety, and stress, are associated with increased risk of GDM and GDM related outcomes.
The retrospective study will compare the impact of modeled associations, among women of NA, AA, and NHW
heritage, with results that will provide insights as to the role of psychosocial factors in GDM related health disparities
among AA and NA women. The prospective study, participants will complete a laboratory stress task while we assess
physiological markers of stress reactivity. Results from the prospective study will provide novel information about the
role of physiological pathways by which combinations of maternal mental health and stress impact blood sugar
metabolization. We aim to improve our ability to identify women at risk and prevent GDM and related complications.

Public health relevance
During pregnancy, gestational diabetes increases the risk of complications and adverse outcomes for mother and child, however about 50% of women are diagnosed without a known risk factor present. This project uses two innovative approaches to help us understand the mechanisms by which mental health and stress impact glucose metabolization during pregnancy and delineate their contribution to gestational diabetes and racial disparities. We aim, to improve our ability to identify women at risk, decreasing the impact of gestational diabetes and related complications.